CHARACTERIZATION AND PRODUCTION OF PARVOVIRUS PROTEINS

The main objective of these studies are (1) to identify and characterize all proteins that are specified by the defective human parovoviruses (AAV) and to determine similarities and differences with autonomous parvovirus proteins, (2) to define the mechanism(s) by which the AAV proteins arise, and (3) to define specific functions of the AAV proteins. We have identified several AAV non- structural proteins which were previously undetected. At least one of these proteins is necessary for viral DNA replication. Post- translational processing does not account for production of any AAV structural proteins although they share large segments of sequences-in-common. It is now clear, however, that these proteins originate from independent in-frame initiations. Mechanisms that regulate expression of AAV proteins are of fundamental interest, and we have now shown that one AAV structural protein is initiated by a condon not known previously to act as an initiation codon in higher eukaryotes. Furthermore, our current findings (i) support a "scanning mechanism" in the translation expression of polycicstronic eukaryotic mRNAs, and (ii) demonstrate that alternative mRNA splicing is required for effective translational expression of the largest AAV capsid protein. Among in vitro translation of viral RNA, electrophoretic and HPLC analyses of V8 proteases, and tryptic peptides and aminoterminal sequencing of purified polypeptides.